Basic Science Core - Animal models

IN-TRAC ANIMAL CORE ABSTRACT
The Animal Model Core will establish a training program to introduce all IN-TRAC participants to the TB field
using a variety of animal models that can translate in silico and in vitro findings into potential application to
humans. Texas Biomed hosts the Southwest National Primate Research Center (SNPRC) and has developed
large NHP programs that incorporate aerobiology, molecular biology and a variety of imaging platforms within
the Animal Biosafety Level 3 (ABSL3). These will be the foundation of the Animal Core. SPECIFIC AIM 1:
Conduct an educational program in the use of animals for research, and alternatives. The use of animals
in research requires consideration of the three R’s (reduction, replacement, refinement). All IN-TRAC participants
will receive training in the considerations of the three R’s during experimental design, selection of appropriate
models to test their specific hypothesis, and the alternate systems available or in development for the
replacement of animals in biomedical research. SPECIFIC AIM 2: Leveraging the mouse model of TB to
study pathogenesis and testing of new therapies and vaccines. The mouse model has been a mainstay for
TB research and remains a useful tool for understanding TB immuno-pathogenesis and for screening drugs and
vaccines for TB. IN-TRAC participants will be introduced to a variety of mouse resources available for TB
research, and will be trained in theory and practice of how to design and conduct studies using rodents, and how
to interpret experimental data with scientific rigor. SPECIFIC AIM 3: Leveraging the NHP model of TB to study
pathogenesis and testing of new therapies and vaccines. Texas Biomed has a unique resource in the
SNPRC that can provide IN-TRAC participants with an in depth training in the use of NHPs in TB research. IN-
TRAC participants will be introduced to a variety of NHP resources available for TB research, and train in theory
and practice of how to design and conduct studies using NHPs, and how to interpret experimental data with
scientific rigor. At the completion of the Animal Model Core, participants will be able to effectively interpret
published data that use rodents and NHP (and other animal models, in part through externships), design
experiments to test their own hypothesis, and participate in TB research that uses animals.